BRAIN EDEMA CLINICAL RESEARCH CENTER

This interdisciplinary research program is directed towards the elucidation of the fundamental mechanisms underlying brain edema and its treatment. The seven individual projects are as follows: 1. Metabolic Basis of Granulocytic Brain Edema; 2. Osmotic Regulation, Neurotransmitter Metabolism and Brain Edema; 3. Pathophysiology of Brain Edema: in vivo Studies; 4. Barbiturates and Ischemic Brain Edema; 5. Increased Intracranial Pressure and Central Neurogenic Pulmonary Edema; 6. Membrane Methylation in Brain Edema; 7. Transport Systems of the Choroid Plexus.